CHD1Li Targeted Combinations with Chemotherapy to Address Unmet Needs in Colorectal Cancer Treatment

PROJECT SUMMARY/ABSTRACT
Cancer therapy has made important advancements in the treatment of aggressive and resistant to standard-of-care
tumors. This progress can be attributed to the significant success of drug combination therapies in multiple cancer types.
Drug combinations have benefitted from our increased knowledge of the mechanisms of resistance, drug metabolism,
and genetic variability observed during tumor progression. Notably, the combination of FOLFIRI (FOLinic acid, 5FU, and
IRInotecan) and bevacizumab (VEGF inhibitor) is used to treat advanced metastatic colorectal cancer. Herein, we propose
the combination of FOLFIRI and Chromodomain Helicase DNA binding Protein 1-Like (CHD1L) inhibitors (CHD1Li) as a novel
synergistic mechanism that will not only decrease the malignant properties of tumor cells, but also sensitize them to the
effects of chemotherapy and other targeted therapies. CHD1L, also known as amplified in liver cancer 1 (ALC1), has been
implicated, through clinical and basic research studies, as an oncogene that affects the outcomes of patients in many types
of cancer. CHD1L is a chromatin remodeling enzyme, and its aberrant function can facilitate tumor progression and tumor
cell survival. In cancer cells, CHD1L promotes malignant gene expression, which leads to an increase in metastatic potential
and tumor heterogeneity. In addition, CHD1L is essential in the DNA damage response and repair, and directly inhibits
programmed cell death mechanisms, enabling tumor cell survival and MDR. These functions of CHD1L, when unregulated
in tumor cells, can significantly lead to an increase in cancer patient mortality. Onconaut Therapeutics Inc. has designed
and optimized a series of first-in-class lead drugs (OTI-600 series) that inhibit CHD1L and display antitumor activity as
single agents, but also synergize with standard of care chemotherapy and targeted therapy. Preliminary data with one of
our lead CHD1Li (OTI-611) demonstrates an excellent pharmacokinetic profile, oral bioavailability, and no observed toxicity
in major organs of tumor bearing mice as a single agent or in combination with chemotherapy. In this fast-track STTR
proposal we will develop and prioritize the best CHD1Li lead drug to enable its transition to an investigational new drug
(IND) with an initial target market of colorectal cancer (CRC). Phase I of this project will focus on performing a
comprehensive in vitro cytotoxicity efficacy assessment of OTI-600 series drugs in patient-derived tumor organoids with
diverse genetic backgrounds as single agents and in combination with FOLFIRI. In tandem, these CHD1Li will be tested for
their pharmacokinetic and toxicologic profiles as single agents and in combination with FOLFIRI in mice. In Phase II, the
best two OTI-600 series drugs will be tested for their efficacy in combination with FOLFIRI in mouse xenografts. Finally,
the best lead drug CHD1Li will undergo scale up synthesis (2 kg) to facilitate preclinical IND-enabling studies.

Public health relevance
PROJECT NARRATIVE CHD1L is an oncogene that drives tumor progression, metastasis, and multidrug resistance in many cancers. CHD1L is overexpressed or amplified in cancer and is a biomarker of poor prognosis and poor overall survival for cancer patients. This proposal will develop a small molecule lead drug targeting CHD1L with a goal for clinical translation to improve cancer patient outcomes.